Clonable Nanoparticles

PROJECT SUMMARY
The objective of this proposal is to address the contrast problem in cellular electron microscopy. The cloneable
fluorophore, Green Fluorescent Protein (GFP), and related fluorescent proteins complement small molecule
stains and dyes to essentially solve the contrast problem in optical imaging. For cellular electron microscopy,
however, contrast options are limited and there are no widely used cloneable contrast agents.
Cloneable contrast in electron microscope imaging of biology can arise from a `cloneable inorganic
nanoparticle (cNP).' A cNP is an NP made by a protein. The protein determines the properties of the
nanoparticle such as elemental composition and shape. Because protein sequence, structure and function are
encoded in DNA, the properties of the nanoparticle are also encoded in DNA. Modifications to DNA encoding a
cNP may modify the resulting cNP. Our cNPs are based on inorganic ion oxidoreductase enzymes. Such
enzymes select for and reduce inorganic biocoordination complexes, creating metal(loid) nanoprecipitates.
Additional proteins/peptides (fused to the enzyme) act as ligands, influencing size, morphology, et cetera of the
nanoparticle. DNA encoding the cNP can be concatenated to DNA encoding any protein of interest. Resulting
protein chimeras contain an integral inorganic nanoparticle. The nanoparticle contrast allows the protein of
interest to be identified against cellular background in electron micrographs.
We have developed a cloneable selenium nanoparticle (cSeNP). We demonstrated cSeNP molecular labeling
of FtsZ filaments in E. coli. The goal of this proposal period is to continue evaluation of this cSeNP and
produce additional distinguishable cNPs. The proposal proceeds in 3 aims. Aim 1 is to evaluate the cSeNP in
Drosophila, as a multicellular model organism, more complex than E. coli. Aim 1 also proposes to label
ribosomal protein L1 in Caulobacter with the cSeNP and other cNPs. Because ribosomes can be
unambiguously identified in electron cryo-tomograms, they provide an internal-standard for evaluation of cNPs.
We will determine efficiency of cNP constructs by assessing what percentage of ribosomes have an associated
cNP label. This assessment identifies shortcomings in cNPs, informing their subsequent refinement. Ideally,
cNPs will emerge that label quantitatively. Aims 2 and 3 engineer different aspects of cNPs. Aim 2 uses
protein design tools to minimize cNP protein size. Aim 2 also proposes directed evolution of cNP enzymes to
produce cNPs of novel elemental composition. Aim 3 is to expand the palette of biomolecules that ligate cNPs,
influencing their resulting size and morphology. Aim 3 will identify proteins within the protein coronas that form
around cNPs, followed by identification of any serendipitous nanoparticle binding domains. Aim 3 also
proposes to isolate nanoparticle binding peptide ligands through ribosome display approaches. Overall, this
proposal is to develop and evaluate a pipeline of many size/shape/morphology distinguishable cNPs,
facilitating multiplexed protein imaging in cellular electron microscopy.

Public health relevance
PROJECT NARRATIVE Images of cells and cellular processes are fundamental to biomedicine. This project is to develop new chemical tools for revealing molecules that cannot otherwise be seen in electron microscope images of cells. Such tools will reveal currently unknown information about where molecules are located in normal and diseased tissues, and cells.